Data Management for Data Sharing: A Short Course for Researchers in Children’s Learning and Development

PROJECT SUMMARY/ABSTRACT
The proposed short course is designed to expose researchers in learning and developmental sciences to
principles and best practices in research data management and data sharing, and to provide scaffolded
support to help researchers to engage in data sharing. The work has four specific aims. Aim 1: To develop a
short course training researchers in children’s learning and development about data management and data
sharing. Aim 2: To deliver a five-day summer intensive short course to early and established career scholars
and enroll them in an online community of practice (Q/A sessions and webinars) for the remainder of the year.
Aim 3. To disseminate the work developed via aim 1 by developing an open educational resource on data
management and data sharing for scholars in the learning and developmental sciences. Aim 4: To evaluate the
proposed project in terms of the knowledge, beliefs, and behaviors. The course will be developed and provided
by core project faculty and consultants with years of expertise in research data management and data sharing.
This team of investigators is uniquely positioned to train researchers in the areas of data management and
data sharing because we include the primary investigators of the LDbase; an NIH funded data repository, and
the only domain-specific data repository for learning and developmental science.

Public health relevance
PROJECT NARRATIVE Through the development and provision of an in-person summer intensive short course, the proposed research training program is designed to expose researchers in learning and developmental sciences to principles and best practices in research data management and data sharing. The course will increase researchers’ knowledge, understanding, and comfort with data management and data sharing practices, remove salient barriers to data sharing, and thereby has the potential to increase the uptake of data sharing in the field of learning and developmental science.